Molecular Vector and Conditional ES Cell Clone Collection Validation and Maintenance Plan by theMMRRC at UC Davis

Molecular Vector and Conditional ES Cell Clone Collection
Validation and Maintenance Plan by the MMRRC at UC Davis
ABSTRACT
This application from the Mutant Mouse Resource and Research Center at the University of California, Davis
(MMRRC) proposes the validation and maintenance for distribution of data, molecular vectors, and ES cell
clones for 4,867 genes targeted as knockout-first alleles produced by the EUCOMM Program. These genes
are unique to the set of conditionally-targeted genes produced by KOMP2 as part of the International Mouse
Phenotyping Consortium (IMPC) and are not currently available or accessible by NIH-funded researchers.
Through an administrative supplement awarded last year, 2,751 vector and ES cell lines of this collection were
acquired and are being transferred to the MMRRC at UC Davis. Arrangements are underway for the transfer
of the balance of 2,116 over the next several months. However, full validation will be required to make the
collection available for dissemination to the research community. To accomplish this goal, the MMRRC will
conduct a number of quality controls steps (e.g., data verification and alignment with biological resources,
concentration and purity of molecular vectors, conditional allele-specific genetic screening, cell morphology
and viability in culture, chimera production and germline transmission, fecundity and viability of live offspring) to
fully verify the identity and validate the utility of the vector and cell resources, produce and publish Strain Detail
Sheets, integrate the collection into the MMRRC inventory, and list the collection in the online MMRRC
catalog. The cost to validate and maintain this resource is a very small fraction (~2%) of what it would cost to
recreate it using CRISPR-mediated gene-targeting. Once fully validated and integrated into the existing
MMRRC inventory, the collection will be available for distribution to the biomedical research community upon
request, especially to NIH-funded investigators who continue to express interest in conditional, lacZ tagged
alleles for their research. As a result of the activities funded by this administrative supplement, expansion of
the MMRRC molecular vector and conditional allele resource will exert a sustained, powerful influence on
research field(s) using conditional mouse models and the overall ORIP mission to support a variety of resource
and research centers that develop animal models of human biology and disease for US biomedical
researchers. The costs to execute this project are beyond the available support provided by the parent
MMRRC grant to UC Davis. If awarded, funds will be used to complete this project during the current grant
year (ending January 31, 2026).

Public health relevance
Molecular Vector and Conditional ES Cell Clone Collection Validation and Maintenance Plan by the MMRRC at UC Davis PROJECT NARRATIVE The Mutant Mouse Resource and Research Center (MMRRC) at UC Davis provides the research community with scientifically unique and valuable mutant mouse molecular vectors, cells, germplasm, and mice for biomedical studies on human health and disease. The ability to selectively manipulate gene expression enables research to understand gene function in specific cells and tissues. This project significantly expands the number of fully-validated molecular vectors and conditionally-targeted embryonic stem (ES) cells for thousands of genes that are not currently available to NIH-funded researchers. Validation and maintenance for distribution of this novel collection of molecular vectors and conditional ES cells will significantly enhance the breadth and depth of complex genetic research resources in the MMRRC that are available to the US research community.